Targeting the Tumor Microenvironment in Patients with AIDS-Associated EBV+ Diffuse Large B Cell Lymphoma

PROJECT SUMMARY
The Ohio State University Comprehensive Cancer Center (OSUCCC) is in its 44th year as an NCI-designated
comprehensive cancer center, having received an “exceptional” overall merit descriptor in its last two reviews in
2010 and 2015, and is requesting continued federal support for the next five years. The OSUCCC mission
remains to reduce cancer morbidity and mortality through basic, population, translational and clinical research.
Through thoughtful strategic planning, attention to the cancer burden in the catchment area (the state of Ohio),
effective organizational capabilities and targeted investment, the Director and his Senior Leadership team will
enable the OSUCCC to advance collaborative cancer research with local, national, and global partners on
initiatives of the highest priority to the OSUCCC. The 293 full and introductory members are currently served by
16 full and two developing shared resources and are distributed among our five Research Programs: Cancer
Biology (formerly Molecular Biology and Cancer Genetics), Cancer Control, Leukemia Research, Molecular
Carcinogenesis and Chemoprevention and Translational Therapeutics. The OSUCCC fosters collaborative basic
research and implements strategies that advance and translate early discovery into clinical and population-based
research and addresses the needs of our catchment area through research, engagement, and outreach, from
etiology through prevention, treatment and survivorship regarding the major cancers afflicting our catchment
area population. The OSUCCC trains the next generation of cancer-focused scientists and clinicians through
new and established programs focused on integrating training for collaborative research efforts. Under the
leadership of a new Director, Raphael Pollock, MD, PhD, The OSUCCC supports innovative research efforts
within four strategic planning priorities: immuno-oncology, cancer engineering, translational genomics and
cancer prevention and survivorship. Since the last CCSG competitive renewal, the OSUCCC has shown
significant growth demonstrated by: 1) the recruitment of 108 basic, population, and translational science faculty
who are OSUCCC members; 2) the addition of 94,647 ft2 research and administrative space under the full control
of the OSUCCC Director; 3) a 16% increase in direct cancer-related funding to $75.4M, with $44.3M coming
from the NCI; 4) accrual of 14,996 patients to interventional clinical trials (5,648 accruals to therapeutic trials); 5)
increased collaborative and impactful research demonstrated by 3,477 peer-reviewed publications in which 74%
of manuscripts are multi-institutional and 85% are collaborative (i.e., inter-, intra-programmatic or multi-
institutional); 497 are published in journals with an impact factor >10; 6) the addition of two new shared resources
at an institutional investment of $1.3M; and 7) preclinical and clinical development of an FDA approved drug
which has changed the treatment for CLL and other blood cancers. With new recruits and strong institutional and
philanthropic support in place, the OSUCCC is building upon the momentum and poised in the next five years to
take significant steps toward achieving our mission and our broad vision of living in a cancer-free world.

Public health relevance
PROJECT NARRATIVE The Ohio State University Comprehensive Cancer Center (OSUCCC) is a matrix cancer center that integrates and leverages all of the resources of the University to achieve its broad vision of creating a cancer free world. The OSUCCC addresses the public health needs of the catchment area (the state of Ohio) through research, education and community outreach and engagement as research conducted within the five OSUCCC Programs focuses on high priority cancers for the OSUCCC including lung, breast, colorectal, prostate, endometrial, cervical cancer, thyroid, and leukemia, as well as tobacco use, obesity, and HPV vaccination. Screening and outreach activities are provided to the populations across the lifespan that we serve, especially those with higher burden of being diagnosed with cancer, such as racial/ethnic minorities and other underserved populations (e.g., rural, LGBTQ+, Appalachian) through targeted, culturally appropriate education activities, free cancer screenings, patient navigation, community networking, environmental scans, and addressing policy issues.